Mutational scanning of seizure-related gene para in fruit flies

PROJECT SUMMARY/ABSTRACT
A single mutation in a gene can lead to a disease. Many mutations, however, are benign. How do we determine
which mutations are pathogenic and which are benign? There are hundreds of millions of single nucleotide
variants in the human genome that have been identified by sequencing, with 5 million of these in protein-coding
DNA. Despite this wealth of data, only ~2% of these variants have clinical annotations, half of which are “variants
of uncertain significance”. High throughput functional screening of variants is thus needed for the millions of
variants that have not been annotated. One approach for studying such large variant libraries is to use a method
called deep mutational scanning, in which a library containing millions of gene variants is screened in parallel.
This approach has proven useful in classifying variants of BRCA1, PTEN, and others by carrying out screens in
cell culture. While this approach has the benefit of scale, it does not enable mutations to be studied in a
developmental or tissue-specific context. However, human genetic diseases, including cancer, are tissue-
specific. It is therefore desirable to study mutations in the context of whole organisms.
We have recently shown in our lab that we can generate many Drosophila melanogaster with genomically
integrated gene variants on the order of 1,000 or more variants at a cost of ~$1/variant for DNA delivery.
Using this new ability to generate large numbers of transgenic D. melanogaster, we propose use a D.
melanogaster seizure disease model to phenotype over 1,000 gene variants of para, a closely related ortholog
to the human gene SCN1A, the most commonly implicated gene in epilepsy. Aim 1a: Generate over 1,000 D.
melanogaster harboring different para variants. Aim 1b: Phenotype the variant flies in parallel using a seizure
assay. Pool flies by their seizure severity, sequence them, and report findings to ClinVar to improve clinical
variant annotation. Aim 2a: Increase the scale of variant libraries that can be made in D. melanogaster by
characterizing more highly efficiency DNA recombinases for genomic integration of DNA into the genome. Aim
2b: Use a gene gun to increase the rate at which DNA is delivered to embryos, up to a thousand or more embryos
per second.
In this work, we will use our recently developed approach for generating large numbers of transgenic D.
melanogaster to perform mutational scanning of over 1,000 variants of para. These results will provide supporting
evidence for variant classification of the analogous variants of the human gene SCN1A, which is very closely
related to para. In this work we will also increase the scale of DNA delivery and efficiency of integration into the
fly genome so that larger numbers of gene variants can be screened in the future. We believe our approaches
will prove very useful for assigning clinical annotations for the vast majority of variants of disease-related genes
that show tissue-specific effects. We also expect the technology to be widely adopted by the developmental
biology community, as it will enable rapid phenotyping of thousands of variants of developmentally important
genes in a whole organism context.

Public health relevance
PROJECT NARRATIVE The clinical relevance of most missense variants observed in human genes is currently unknown, because so many possible variants exist and most have not been observed in the clinic enough times for their effect to be known. The proposed work will enable the rapid phenotyping of thousands of gene variants in parallel in a multicellular eukaryotic organism for the first time and will provide evidence for clinical classification of over 1,000 variants of the D. melanogaster ortholog of the very closely conserved human SCN1A gene. This technology will improve disease screening, diagnosis, and prognosis by rapidly characterizing and annotating which variants seen in the human genome contribute to pathogenicity.